Administrative Core

Summary, Administrative Core
The proposal “Thalamus in the middle: computations in multi-regional neural circuits” aims to combine expertise
in theory, molecular neuroscience, modern high-throughput anatomy, cellular and synaptic neurophysiology, and
large-scale neurophysiology in the context of quantitative behavior. The overall project consists of five Projects,
focusing on how information flows from subcortical areas, through thalamus, to control cortical activity modes
and thereby shape behavior; a Molecular Science Core, a Data Science Core, and an Administrative Core with
5 PIs and two collaborative sites. Realizing the potential of this project requires strong administrative leadership
to integrate and synergize efforts across the collaborating researchers at New York University and the Allen
Institute.
The Administrative Core will provide the structure, leadership and operational management of the overall project
to advance the goal of understanding neural computation in subcortex → thalamus → cortex circuits. This will
include project management, strategic planning, progress reporting, fiscal management, and support for
collaboration and communication. The Administrative Core will create an infrastructure that fosters
communication and collaboration among the members, as well as garnering input from the external research
community through the formation of an External Scientific Advisory Board. The overall project will form a Steering
Committee and Project Teams to oversee the collaborative, standardized, and on-time data generation, data
analysis, and public data sharing process. Project management best practices, such as milestones, progress
reporting and tracking, collaborative software programs, and a responsibility matrix will be applied to ensure
achievement of performance objectives and milestones, optimized communication, and resource utilization and
prioritization. In addition, the Administrative Core will foster joint data analysis efforts across projects and
Institutions. To produce a high-quality tools and data resource, rigorous standardization and quality control
practices will be adopted by all members. Finally, the Administrative Core will implement and maintain fiscal and
subcontractor management processes for all members, manage publication and authorship decisions and
conflict resolution. With the implementation of this entire infrastructure, we anticipate that this project and the
resources it produces will have a broad and meaningful impact on uncovering the logic of signal routing from
subcortical areas to the frontal cortex thalamus.

Public health relevance
Narrative, Administrative Core The Administrative Core will provide the leadership and organizational structure to align the efforts of the individual Institutions, projects and researchers to meet the overall goals and milestones. This will involve integrating and aligning the efforts of five Research Projects (detailed map of region-specific and cell type- specific connectivity between subcortex, thalamus, and cortex; connectivity based on electrophysiology and optogenetics; high-density electrophysiology in multi-regional circuits; and multi-regional network models of computation and behavior), the Molecular Science Core (thalamocortical molecular tools), and the Data Science Core. The Administrative Core will oversee the operational management including strategic planning, project management, progress reporting, fiscal management, manuscript and authorship planning, conflict resolution and support for collaboration and communication to create, integrate, and disseminate to the community high- value anatomical and neurophysiological data as well as cloud-based data analysis workflows.